Spatiotemporal and molecular determinants of autoimmune T cell stemness and differentiation in type I diabetes

PROJECT SUMMARY
Type I Diabetes (T1D) is a T cell mediated autoimmune which is dramatically increasing in incidence. The
pathogenesis of T1D is complex and involves the infiltration of β cell-specific CD8 T cells into the pancreas and
progressive destruction of insulin-producing b cells, resulting in loss of glucose homeostasis. Utilizing the
clinically relevant Non-Obese Diabetic (NOD) mouse model of T1D, the Schietinger lab recently discovered a β
cell-specific stem-like CD8 T cell population in the pancreatic lymph node (pLN) which self-renews and gives
rise to differentiated progeny that migrate to the pancreas and destroy β cells; pancreatic T cells are short-lived
and stem-like T cells in the pLN must continuously seed the pancreas to sustain β cell destruction. In this
application I aim to understand the underlying molecular and cellular mechanisms that determine autoimmune
T cell differentiation. In aim 1, I will determine how and where stem-T cells self-renew and differentiate, employing
imaging cytometry and spatial transcriptomics technologies. In aim 2, I will define the functional role of
transcription factors associated with T cell stemness through gain and loss of function approaches. Finally, in
aim 3, I will ask whether perturbation of pLN intranodal positioning or inhibition of stem-T cell associated signaling
molecules disrupt autoimmune T cell differentiation and prevent T1D onset. These proposed studies are
designed to obtain a deep mechanistic understanding of the spatiotemporal and molecular factors that determine
autoimmune T cell differentiation which could lead to novel therapeutic targets for T1D and other T cell-mediated
autoimmune diseases.

Public health relevance
PROJECT NARRATIVE This project will elucidate the spatiotemporal and molecular mechanisms of autoimmune CD8 T cell differentiation in Type 1 Diabetes. The proposed research will provide key insights for the development of novel therapies targeting T cells for prevention and treatment of Type 1 Diabetes and other T cell-mediated diseases.